Calibration Tools For PC-Based Vision Enhancement

Principal Investigator/Program Director (Last, first, middle): Dagnelie, Gislin RESEARCH & RELATED Other Project Information 1. * Are Human Subjects Involved? l Yes m No 1.a. If YES to Human Subjects Is the IRB review Pending? l Yes m No IRB Approval Date: Exemption Number: 1 2 3 4 5 6 Human Subject Assurance Number 00001079 2. * Are Vertebrate Animals Used? m Yes l No 2.a. If YES to Vertebrate Animals Is the IACUC review Pending? m Yes m No IACUC Approval Date: Animal Welfare Assurance Number 3. * Is proprietary/privileged information l Yes m No included in the application? 4.a.* Does this project have an actual or potential impact on m Yes l No the environment? 4.b. If yes, please explain: 4.c. If this project has an actual or potential impact on the environment, has an exemption been authorized or an environmental assessment (EA) or environmental impact statement (EIS) been performed? m Yes m No 4.d. If yes, please explain: 5.a.* Does this project involve activities outside the U.S. or m Yes l No partnership with International Collaborators? 5.b. If yes, identify countries: 5.c. Optional Explanation: 6. * Project Summary/Abstract 5515-Abstract.pdf Mime Type: application/pdf 7. * Project Narrative 8219-narrative.pdf Mime Type: application/pdf 8. Bibliography & References Cited 5937-Bibliography.pdf Mime Type: application/pdf 9. Facilities & Other Resources 7753-Facilities.pdf Mime Type: application/pdf 10. Equipment 3779-Equipment.pdf Mime Type: application/pdf Tracking Number: Other Information Page 6 OMB Number: 4040-0001 Expiration Date: 04/30/2008 Principal Investigator/Program Director (Last, first, middle): Dagnelie, Gislin Project Summary/Abstract A hardware/software toolkit will be created to will allow personal computers to be used as accurately calibrated and controlled vision test instruments. This toolkit is predicated on the fact that modern PCs and displays (ei- ther CRT-based or flat screen) have sufficient computing power, resolution, and stability to function as reliable measurement tools. A major advantage of PC use for vision testing is that measurement software can be equipped with a high level of fault tolerance. Automated test routines including criterion-free and forced-choice procedures, catch trials, Bayesian threshold approximation, and other sophisticated psychophysical techniques can greatly allevi- ate the need for highly-trained technicians, and the operator's main task can be to make sure that the test sub- ject is cooperative. This fault tolerance does not automatically extend to the setup and calibration of hardware, however. Screen intensity and chromaticity, test distance, room illumination, and a number of other variables can have a significant effect on test thresholds, even when testing the same subject on the same PC under similar conditions. We propose to develop a set of simple hardware tools and control software that will allow necessary hard- ware calibrations and setup to be performed quickly, reliably, reproducibly, and with a very modest level of training on the part of the operator. Under this phase I application we designed a prototype toolkit with hard- ware based on off-the-shelf components and software with a relatively primitive user interface. Under the sub- sequent phase II application we will develop a fully integrated hardware prototype, a fault-tolerant software package with a user-friendly interface, and a detailed product development and commercialization plan. Project Description Page 7